Resource Development Core

Modified Project Summary/Abstract Section

RESOURCE DEVELOPMENT CORE
ABSTRACT

Kidney health is a growing area of research interest in the scientific community, and new resources are needed to ensure this work harnesses the full spectrum of research (basic, clinical, and translational) with excellence and rigor. The Resource Development Core (RDC; Co-Directors: Joe Coresh, MD, PhD and Jen Pluznick, PhD) of the Johns Hopkins O’Brien Center to Advance Kidney Health will develop new and refine existing resources for the conduct of basic and clinical research relevant to kidney health. Mature
resources will be transferred to the Biomedical Resource Core (BRC) and shared with the broader scientific community. We will work to anticipate the needs of the research community so that we appropriately prioritize investments and will continuously develop new ideas at Johns Hopkins as part of a dynamic incubator space connected to national needs. The RDC will validate all new resources and share them with the BRC for
maintenance and local and national dissemination. We will leverage the strength of Johns Hopkins in kidney health which spans from basic science to clinical science to epidemiology, to advance two Aims. In Aim 1, we will develop new clinical science resources to advance kidney health. In this aim, we will build on a strong foundation in this area in order to innovate and build new resources including metrics of social
determinants of health, validating and interpreting proteomic findings, and including and calibrating risk equations to social determinants of health. In Aim 2, we will develop new basic science resources which uncover mechanisms underpinning kidney disease. In
Year 1, our basic science efforts will focus on establishing two key resources for the research community focused on brain-kidney crosstalk during stressors, and gut microbiota and sex differences. We will work to not only make mouse models widely available through the BRC, but critically, will also develop Sample Banks (including tissues, blood, and urine) through which researchers can easily explore these models with minimal logistical and financial burden. In Years 2-5, we will establish new models addressing kidney health and likewise transfer to the BRC both mice and Sample Banks. Together, the two Aims of this proposal will provide new resources to propel forward research addressing kidney health.